Determining how a single-residue PKR mutation found in patients with familial dystonia causes aberrant PKR activation

Project Summary/Abstract
Protein Kinase R (PKR) is a ubiquitously expressed serine/threonine kinase that recognizes double stranded
RNA (dsRNA). Upon binding viral dsRNA, PKR homodimerizes and autophosphorylates, activating PKR Kinase
activity. Phosphorylated PKR will then go on to phosphorylate various targets, including the well-characterized
eIF2α, to initiate translational shutdown in the cell. This translational shutdown is important for limiting viral
replication and spread. Intriguingly, active PKR can also be detected in the absence of viral dsRNA in a variety
of different neurologic diseases, including Alzheimer’s disease, Huntington’s disease, and amyotrophic lateral
sclerosis. However, the underlying molecular mechanisms for PKR activation in neurodegenerative diseases are
incompletely understood. Recently, several mutations, all located in the dsRNA binding domain of PKR, have
been associated with early onset generalized dystonia, a neurologic disease characterized by an uncontrollable
writhing motion. This suggests that abnormal PKR activity can play a causal role in neural disease. Additionally,
despite the ubiquitous expression of mutant PKR, disease was restricted exclusively to the nervous system.
Notably, a single-residue glycine-to-arginine mutation (G130R mutation) was found in several independent
families. The G130R mutation was associated with a mild increase in PKR activation in sampled patient
fibroblasts following PKR stimulation with poly I:C (a viral dsRNA mimetic).
By expressing wildtype PKR (PKRWT) or PKR harboring the G130R mutation (PKRG130R) in human cells,
we have found that expression of PKRG130R, but not PKRWT, leads to PKR phosphorylation in the absence of
other stimuli, apparently indicating a gain-of-function mutation. The goal of this proposal is to determine the
molecular mechanism of how G130R causes PKR overactivation. Our group recently found that neurons
intrinsically express high levels of long dsRNA structures, and that these self-dsRNAs can activate PKR. We
hypothesize that the PKRG130R mutation is an activating mutation that enhances PKR binding affinity for self-
dsRNAs in neurons. Therefore, autoinflammatory PKR reactions against self-dsRNAs may be an early event
that causes neurodegeneration. Specifically, our aims are: 1. Determine the mechanism of PKRG130R activation
by both dsRNA affinity as well as protein-protein interactions, 2. Determine the identity and properties of the
specific transcripts that bind mutant PKRG130R compared to PKRWT, and 3. Utilize human embryonic stem cell
technology to determine which cell types PKRG130R is overactivated in, and what features cause PKRG130R to be
overactivated in those cell types. We believe that identifying the mechanism of PKRG130R activation may provide
insight on PKR dysregulation in neurologic disease states. Understanding how PKR activity is controlled by self-
dsRNAs could uncover specific RNA species or RNA associated pathways for targeted therapy to modulate PKR
activation and could be applied to a host of neural diseases that share PKR overactivation as a common feature.

Public health relevance
Project Narrative 1. PKR is a pattern recognition receptor which binds dsRNA, and that is overactivated in a variety of debilitating neurologic diseases (including Huntington’s disease, Alzheimer’s disease, and Aicardi-Goutières syndrome). 2. The G130R mutation in PKR leads to enhanced PKR activation both in patient fibroblasts with familial neurologic disease as well as in our cell culture system, but the mechanism of overactivation is not known. 3. This proposal will attempt to identify the cause of PKRG130R overactivation and its role in causing neurodegeneration, which may help identify strategies for future therapeutics for a range of different neurologic diseases where PKR is overactive.